Arise: An Online Relapse Prevention Tool for Substance Abusers

Modify Phase I product and develop the full Arise product. Modify initial prototype based on feedback and fully develop all six modules.